600MHz NMR Spectrometer

Project Summary
We propose to acquire a Bruker Avance Neo 2-channel 600 MHz NMR spectrometer with a
BBFO CryoProbe and a SampleCase automation device, to be housed in the NMR Facility at
the Barnett Institute of Northeastern University. This versatile configuration will transform the
capabilities of the two aging and oversubscribed instruments in our NMR core, a 500 MHz
Varian INOVA and a 400 MHz Varian Mercury Plus, to meet rapidly increasing demands for
chemical and biological structural analysis.
The cutting-edge CryoProbe and automation capabilities of the requested 600 MHz NMR will
enable a range of innovative projects at the forefront of interdisciplinary biomedical research,
leaving routine usage to the existing NMR instruments. The following NIH-funded projects of
the major users of the instrument will benefit immediately from the new features of the
instrument: Kinetic target-guided synthesis to modulate protein-protein interactions (R.
Manetsch); Discovery of lead and tool compounds for probing and modulating protozoan
parasite biology (M. Pollastri/L. Ferrins); de novo synthesis of biologically active natural
products and carbohydrate motifs (G.A. O’Doherty); Targeting the endocannabinoid system in
treating brain disorders (A. Makriyannis); Profiling secondary metabolites in cell extracts of
uncultured bacteria (K. Lewis); Improving oligonucleotide biopharmaceuticals by steric
protection (K. Zhang); Dynamics of processivity clamp proteins in bacterial DNA replication (P.
Beuning); and Transport of biologically active molecules across tight epithelial barriers (W.
Lencer, Harvard Medical School).

Public health relevance
Project narrative The requested nuclear magnetic resonance (NMR) spectrometer will provide essential analytical capabilities for 150+ scientists at Northeastern University conducting NIH-supported research, which provides public health benefits including discovery of new anticancer drugs, nanotechnology for targeted drug delivery and tissue engineering, treatments for malaria and neglected global diseases like sleeping sickness, non-addictive medications for chronic pain, and treatments for addiction to cocaine or methamphetamine.